2017 Preclinical Form & Formulation for Drug Discovery Gordon Research Conference & Gordon Research Seminar

Title: Preclinical Form & Formulation for Drug Discovery Subtitle: Drugs as Materials June 4-9, 2017 ? Stoweflake Mountain Conference Center, Stowe, VT Chairs: Eric Munson & Narayan Variankaval Vice Chairs: Elizabeth Topp and Karthik Nagapudi The 2017 Preclinical Form & Formulation for Drug Discovery Gordon Conference and Gordon Research Seminar will present cutting-edge research on enabling formulations for the improved stability and bioavailability of drug candidates. The focus of this GRC is on the recognition that drugs are materials, and how the integration of that philosophy creates an interdisciplinary approach to drug development. New topics for this installment of the conference series include Biomolecular Drug Characterization, Novel Manufacturing Methods, and Mechanochemistry. The conference will bring together academic and industry leaders in pharmaceutical materials science, preclinical formulation science, and biopharmaceutics . Experts from a wide range of disciplines, including those outside preclinical formulation, will discuss both scientific and technological advances that translate to better formulations for preclinical to early clinical studies. Additionally, ways that science and technology could transform the field to bring drugs to the market faster and safer will be explored. The conference will focus on educating the next generation of scientists and researchers through the Gordon Research Seminar as well as their participation in the Gordon Research Conference. Priority will be placed on the inclusion of underrepresented groups as participants in the conference.

Public health relevance
Project Narrative The goal of the 2017 Preclinical Form and Formulation in Drug Discovery Gordon Research Conference is to bring together academic and industry leaders to develop innovative solutions to the increasing challenges in drug delivery. This conference will focus on identifying the pharmaceutical challenges facing the translation of new drug candidates to the patient, developing predictive strategies for decreasing time and improving the success of small molecule and biologics delivery, and highlighting new tools and techniques for characterizing drug formulations.